Tumor-expressed immune checkpoint B7x-mediated resistance to anti-CTLA-4 therapy.

Tumor-expressed immune checkpoint B7x-mediated resistance to
anti-CTLA-4 therapy
Immune checkpoint blockade of CTLA-4 and PD-1/PD-L1 have advanced
the treatment of cancer patients. However, one of the biggest challenges is that
the majority of cancer patients do not respond to these treatments. Based on our
new results, our central hypothesis of this proposed revision research is that
tumor-expressed immune checkpoint B7x induces resistance to anti-CTLA-4
therapy and that combination treatment of anti-B7x and anti-CTLA-4 leads to
synergistic therapeutic efficacy and overcomes the resistance to anti-CTLA-4
therapy. Guided by our published clinical and basic research, and our strong
preliminary data, we will pursue two specific aims: 1) Dissect the mechanisms
underlying tumor-expressed B7x mediated resistance to anti-CTLA-4 therapy;
and 2) Develop novel combination therapies of anti-B7x and anti-CTLA-4 to
overcome the resistance. We have generated a number of novel tools for this
project. The outcomes of this project will reveal new mechanisms underlying
tumor-expressed B7x-mediated resistance to anti-CTLA-4 therapy and will
develop into new immunotherapies overcoming the resistance.

Public health relevance
The proposed research is directly relevant to public health and NIH’s mission, because our program will result in new functional and mechanistic understanding of the resistance to anti-CTLA-4 therapy. This new insight will directly translate into novel immunotherapies to overcome the resistance to anti-CTLA-4 drug.